Compounded Neuronal Damage in Comorbid Cigarette Smoking and Addiction

Abstract
The negative health consequences of cigarette smoking (CS) are indisputable: extensive heart and lung
damage and significant risk for multiple types of cancer. Similarly, the addictive properties of CS are also well-
documented. Epidemiological studies have repeatedly shown that cigarette addiction is highly comorbid with
alcohol and other substance use disorders (AUD, SUD). Discussions of these data typically center around
concern for the serious peripheral health consequences of smoking and/or risk for relapse for AUD/SUD.
While these are worthy topics of inquiry, the current state of the literature has failed to address several critical
points: first, while smoking rates are decreasing in the general U.S. population, they remain high in AUD/SUD.
Second, while we know that the toxic compounds in combustible tobacco products are highly likely to induce
brain damage, we do not yet have an understanding of putative dose-response functions of smoking history
and current CS status on markers of neural damage. Third, it is not known how lifetime CS exposure interacts
with other addictions at the level of brain structure and biochemistry to produce behavior: this could be key for
discovering how the cycle of comorbid addictions is perpetuated, and thus is crucial for advancing treatment
and predicting outcomes. Recently, a wealth of neuroimaging studies have emerged that have examined brain
structure in chronic smokers. However, the majority of these studies looked at single outcome variables, only
considered cigarette addiction, and did not design the studies from a perspective of a brain damage
hypothesis. What are missing is information derived from comprehensive, multi-modal studies that attempt to
understand the caustic effects of CS on the brain, and data that inform us of how CS exposure may compound
effects of and complicate outcomes in CS comorbid with AUD/SUD. Lack of such knowledge is an important,
clinically relevant problem, as it prevents us from developing targeted, mechanism-driven therapies designed
to promote both smoking cessation and alcohol/drug abstinence, and to mitigate or repair brain damage from
CS. We propose to address this critical knowledge gap by applying state-of-the art neuroimaging technologies
to determine how the lifetime dose response function of CS exerts negative consequences on the brain in
AUD. We will conduct parallel studies at the Indiana University School of Medicine and Stanford. Both sites
will recruit the following samples: never-smoking controls, currently-smoking controls, never-smoking AUD,
former-smoking AUD, and currently-smoking AUD. All AUD subjects will be nontreatment-seeking and active
drinkers. We will test the effects of lifetime CS exposure on brain metabolites (Aim 1), white matter tract
integrity (Aim 2), and brain network function (Aim 3). Exploratory Aim 4 will develop a predictively valid model
of the relative contributions of CS-mediated brain damage on neurocognition and drinking behaviors. The
dual-site design maximizes the power of the study by sampling two geographically distinct populations, and
has a built-in replication component that is crucial, but often not realized in human neuroimaging studies.

Public health relevance
Project Narrative There is a very high rate of cigarette smoking in individuals with an alcohol use disorder (AUD), however, we know very little about how the combination of hazardous alcohol use and cigarette smoking impact brain health and cognition. This application will use several advanced brain imaging techniques to understand the additive adverse effects of smoking on brain chemistry, structure, and function and cognition in AUD. The outcomes of this work will help speed development of treatments for both alcohol and cigarette addiction.